Human Microbiome: Diversity, Selection and Adaptation

ABSTRACT
Support is requested for a Keystone Symposia conference entitled Human Microbiome: Diversity, Selection and
Adaptation organized by Drs. Suzanne Devkota, Jeff F. Miller and Roberto G. Kolter, with scientific programming
input from Keystone Symposia. The meeting will take place February 18–21, 2025 at Fairmont Banff Springs
in Banff, Alberta, Canada.
Recent studies suggest that half of every person's microbial gene content may be entirely unique. This
conference aims to bring together researchers studying hosts and microbiomes, with those studying fundamental
microbiology, microbial genetics and microbial ecology to spark deeper and more mechanistic research in the
microbiome field. The conference program will focus on our emerging understanding of the diversity of the human
microbiome and its functional consequences in the selection and adaptation processes that shape human-
microbiome interactions in health and disease. Pioneering tools and technologies to interrogate microbial
genetics and microbial community composition will be featured, alongside innovative strategies to integrate these
data with discoveries regarding host-microbe interactions, adaptations and impacts. Additionally, this conference
will be held jointly with another Keystone Symposia meeting on Host-Microbe Co-Evolution in Human Health:
The Microbiome-Pathobiont Continuum to enable cross-disciplinary insights and collaborations towards a more
comprehensive and integrative understanding of the holobiont.

Public health relevance
PROJECT NARRATIVE The human body coexists with numerous microbial ecosystems that have benefit for both host and microbe, but certain microbes associated with humans may contribute to diseases including inflammatory bowel diseases, digestive disorders and cancer. This Keystone Symposia conference will focus on the knowledge gaps in microbiome sciences as we strive for deeper mechanistic understanding of the assembly of the human microbiome and its broader effects on human health and disease. Together with a joint meeting on Host-Microbe Co-Evolution in Human Health: The Microbiome-Pathobiont Continuum, this conference will address the fundamental mechanisms of microbiome structure, diversity and maintenance, alongside bacterial pathogenesis and the myriad ways that microbes interact with our immune system.